Structure, function, and evolution of the Cryptococcus MAT locus

The Cryptococcus genus spans a diverse group of fungal species from environmental saprophytes to
common human pathogens. In fact, the Cryptococcus neoformans and Cryptococcus gattii species complexes
cause >220,000 life-threatening infections each year in both immunocompromised and immunocompetent
patients, leading to >180,000 deaths, >15% of all HIV/AIDS-related deaths, and >70% mortality in low-income
countries. In studies supported by this award, we defined the structure, function, and evolution of a large genomic
region in Cryptococcus species that has co-evolved with pathogenesis, the fungal mating type (MAT) locus. The
Cryptococcus MAT locus is a large, complex gene cluster that controls sexual reproduction, infectious spore
production, and pathogenicity. We elucidated how these sex- and virulence-determining genes evolved from a
nonpathogenic ancestral state. Our studies reveal bipolar/inbreeding mating systems are shared by all of the
pathogenic species, and evolved from an ancestral outbreeding/tetrapolar system. Similar transitions occurred
in other fungal pathogens of plants and animals, suggesting convergent evolution in concert with host adaptation.
In the prior award period, we made major advances characterizing the association of fungal MAT locus
evolution with virulence: 1) we sequenced the genomes/MAT loci of 24 species spanning all Cryptococcus
pathogens and aligned nonpathogens; 2) we defined Cryptococcus centromeres and implicated inter-
centromeric recombination in mating type and genome transitions; 3) we demonstrated the MAT-encoded RPL22
genes have essential, specialized functions. In the current proposal, we hypothesize that mating-type transitions
drove pathogen emergence resulting in a gene complex linked to virulence and infectious spore production.
Our recent studies reveal unique aspects of MAT biology allowing us to propose new aims to test this
hypothesis. Aim 1 focuses on MAT locus structure and evolution, utilizing RNA-Seq and sRNA analysis to
define mRNA, asRNA, lncRNA, and siRNA produced by MAT during asexual/sexual reproduction, engineering
translocations to model tetrapolar-bipolar transition with CRISPR, and conducting Hi-C analysis to examine
nuclear organization of MAT and centromeres. Aim 2 will elucidate MAT functions linked to virulence and
development involving 1) MAT-encoded lncRNA ASM1, 2) diverged, specialized, essential ribosomal genes we
hypothesize operate as an ancestral imprinting system ensuring sexual reproduction fidelity, and 3) modeling in
mice of the role of a newly recognized host factor controlling immune protection against cryptococcal infections:
host GM-CSF signaling. Auto-antibodies against the GM-CSF cytokine are a major risk factor for lineage-specific
Cryptococcus infections, suggesting unique host features might play a role in evolution of infections due to
human pathogenic species. These studies will advance understanding of dynamic microbial genome evolution,
associating specific gene clusters to virulence and revealing unique host susceptibility determinants, with direct
implications for infectious disease evolution, treatment, and prevention.

Public health relevance
The goal of this proposal is to elucidate the evolutionary trajectory of the mating type locus (MAT) and how this region controls sexual development and pathogenicity of the human fungal pathogen Cryptococcus. This eukaryotic pathogen is a complex of related infectious species that are of significant global public health impact, and which infect both immunocompromised and immunocompetent individuals to cause life- threatening diseases of the lungs and brain (pneumonia, meningoencephalitis); together these species are responsible for >220,000 infections each year, and more than 181,000 deaths worldwide resulting in >15% of all HIV/AIDS associated deaths. Recent studies, including our own, have implicated auto-antibodies to the cytokine GM-CSF as a risk factor for C. gattii infections in humans, and we will employ animal models to study the impact of loss of GM-CSF signaling as a risk factor for cryptococcal infection, and assess this in the context of the distinct species in this pathogenic complex and the contributions of mating types to virulence.